BIOAVAILABILITY STUDY OF LEVOTHYROXINE (300 MCG) PREPARATIONS

The objective of this investigation was to evaluate and compare the pharmacokinetic and bioavailability profiles of two formulations of levothyroxine in healthy female volunteers.